"CANCER MOONSHOT BIOBANK ONLINE CATALOG.

The National Cancer Institute’s (NCI) Cancer Moonshot Program is intended to accelerate cancer research in key strategic areas that were identified through a “Blue Ribbon Panel” (BRP) of experts. Core elements of the BRP recommendations include accelerating progress in cancer research by addressing critical scientific questions. Also included is the need for nationwide participation in research by patients that represent the diversity of the U.S. population. NCI has initiated the Cancer Moonshot Biobank to accelerate research through the collection and distribution of biospecimens for key research efforts. The Biobank will engage with over one thousand cancer patients, being treated with standard-of-care therapies, for longitudinal biospecimen collection. In keeping with the BRP recommendations, the cancer patients will be enrolled into the study from a diverse participant population engaged at medical institutions throughout the U.S. The biospecimens will be distributed to qualified scientists to accelerate research progress. The Biobank program, working closely with Leidos Biomedical, Inc. (LBR), will partner with community hospitals and other medical institutions, designated as Biospecimen Source Sites (BSS), to engage and consent eligible participants and collect biospecimens and associated clinical data; work with a central Biospecimen Core Resource (BCR) to support biospecimen collection, processing and storage activities and perform pathology quality control; work with LBR’s Molecular Characterization (MoCha) lab to perform clinical tumor molecular characterization assays and return results to patients and their physicians; and make the biospecimens and associated data available through an online catalog system to researchers to accelerate cancer research progress. Return of clinical results, a dedicated Patient and Provider Engagement (PPE) website, electronic informed consent, local participant engagement projects, and an embedded ethical, legal and social issues sub-study will together support patient and provider engagement in the program.